CANCER CENTER SUPPORT GRANT

The UCSD Cancer Center is an Organized Research Unit of UCSD. Comprised of 129 members in 15 University departments, it is located at UCSD Medical Center near downtown San Diego as well as at the campus of UCSD in La Jolla. Its mission is to reduce the incidence of and morbidity and mortality from cancer in San Diego County. UCSD Cancer Center is the research component of a University-wide Cancer Program integrating research, teaching and patient care. The Cancer Center has had continuous CCSG funding since April 1, 1979 and is oriented toward excellent basic research with an emphasis on translational research. Over 500 patients are placed on clinical protocols annually; more than half of these on institutional protocols. Dr. William Hryniuk is the Center Director and is also Associate Dean for Oncology Programs. He reports to the Dean of the School of Medicine. Oversight and counsel regarding the Center is provided to the Dean by the Dean's Advisory Group configured specifically for this purpose, and comprised of senior University executives. The Center Director is advised by a Cancer Center Executive Committee with three subcommittees (research education, protocol review, and senior clinical advisory), and by members of the UCSD Cancer foundation, a group of committed and influential citizens of the community. The Cancer Center's research is conducted through seven highly productive large programs carried out in 58,602 (ASF) of space for cancer research of which 30,650 ASF are under the direct control of the Center Director. Grants in support of cancer research total over $20 million (direct costs) which represents a five-fold increase in seven years. This increase is attributable to expansion of existing programs, and recruitment and support of additional senior investigators. The dramatic increase in the size, scope, and number of the research programs is a reflection of the strong and continued commitment of the parent institution. The programs are: Clinical Investigation & Developmental Therapeutics, Cancer Genetics, Basic and Applied Immunology, Glycobiology, Growth Control, Molecular Virology, and Cancer Control and Prevention. There is also a broad and intensive research education program. A stem cell transplantation program is in development. To facilitate translational research, the clinical care activities have been organized into a matrix of clinical services and site-oriented programs. The matrix interlocks with the research programs. Efforts are being made to increase the patient base in order to further facilitate translational research and clinical trials. Funds are requested in this application for shared resources which include Biostatistics, Clinical Trials Office, Flow Cytometry, Pharmacology Lab, Tissue Bank, Molecular Biology Lab, and Lab Support Services. In addition, support is requested for new shared resources of Glycobiology and a Transgenic Mouse Facility to support the basic research strengths of the Center. An amount is requested in the first year of $612,528 for shared resources, and $309,277 for senior leadership and administration.